Targeting BFL-1 in Acute Myelogenous Leukemia

PROJECT SUMMARY
Targeting BCL-2 represents a major advance in the treatment of acute myelogenous leukemia (AML).
However, roughly 35% of treatment-naïve patients and 70% of patients who relapse after standard
chemotherapy induction do not respond to the BCL-2 antagonist venetoclax. There are other anti-apoptotic
proteins BCL-2 family proteins that are potential targets in AML. There have been recent attempts to target
MCL-1, but cardiac toxicity has been observed in some patients treated with MCL-1 antagonists. While it may
be possible to overcome this liability, it is prudent to investigate alternative proteins. BFL-1 (also known as A1)
is another anti-apoptotic protein that is expressed in myeloblasts. Like BCL-2 and MCL-1, it inhibits apoptosis
by binding pro-apoptotic proteins using a hydrophobic BH3-binding groove that is similar to but functionally
distinct from the others. We have previously used BH3 profiling to identify BCL-2 dependence in AML and
guide pre-clinical and clinical development of venetoclax in AML. With collaborators, we have previously
identified a BH3 peptide, FS-1, that binds BFL-1, but no other anti-apoptotic protein, with high affinity. When
used in our BH3 profiling assay, therefore, mitochondrial sensitivity to FS-1 identifies cells that are BFL-1
dependent, and hence candidates for a putative small molecule inhibitor of BFL-1. We have identified BFL-1
dependence in a subset of AML patients. While there are some reports of attempts to identify drugs that target
BFL-1, none have yet made it into the clinic, or even advanced pre-clinical studies. Here we propose a Project
to better understand BFL-1 dependence in AML, to test the efficacy of BFL-1 inhibition in AML, and to develop
small molecules selectively targeting BFL-1.
Our laboratory has a unique array of tools we can deploy for this study, including recombinant BFL-1 protein,
BH3 profiling, cellular and mitochondrial models of BFL-1 dependence, a peptide tool BFL-1 inhibitor
compound, and AML patient-derived xenograft (PDX) models. In addition to our biological studies, we propose
medicinal chemistry experiments to improve existing BFL-1 targeting efforts. Other putative BFL-1 inhibitors we
will test include existing BH3 mimetic lead compounds, CDK9 inhibitors, FOXM1 inhibitors, and others
discovered from our functional screens. The output of this Project will be a comprehensive understanding of
the utility of targeting BFL-1 in AML, biomarkers associated with response to BFL-1 inhibitors and improved
single agent and combination therapies that target BFL-1 in AML.

Public health relevance
PROJECT NARRATIVE Despite exciting recent advances, most people diagnosed with acute myelogenous leukemia (AML) die of their disease. An important recent advance in AML involved targeting a protein, named BCL-2 that keeps leukemia cells alive, so that its targeting kills leukemia cells. Here we propose investigations into targeting the BFL-1 protein, closely related to BCL-2 and also present in leukemia cells, with the goal of eliminating leukemia cells.